High-throughput Clinical Hyperpolarized 13C MRI

PROJECT SUMMARY
This application requests funding to purchase a clinical grade NVision Polaris™ C13 polarizer.
This instrument allows hyperpolarization of C13 substrates, providing more than a 10,000-fold
increase in MRI signal. Metabolic imaging with hyperpolarized C13 substrates allows objective
measures of the injected substrate and its metabolic products to track key metabolic pathways in
real-time. The potential of C13 metabolic imaging has been demonstrated in 30+ clinical trials of
prostate, breast, cervical and brain cancer patients worldwide. Hyperpolarized C13 MRI is safe,
and more than 800 patients have been scanned. In cancer imaging, C13 MRI can allow more
accurate detection of tumors, disease progression, and treatment response. There are also non-
cancer applications where metabolic derangement may serve as an early or precise biomarker,
for example alteration in neurodegenerative disorders such as Alzheimer’s or liver dysfunction.
Installation of this clinical C13 polarizer at our institution will be revolutionary for several reasons.
First, it will be FDA-approved for human use and MGH would be the only site in New England to
have this capability. Second, this instrument can be used on our PET/MR system, which would
enable combination C13 MRI-PET imaging. Third, this polarizer uses a different technique to
achieve hyperpolarization known as parahydrogen induced polarization, with the resulting
advantage where a clinical-grade sample can be produced every 5-10 minutes—a 1/10th of the
time in comparison to prior-generation systems—allowing for seamless integration into a clinical
imaging workflow and for whole-body imaging studies. Lastly, there are several laboratories in the
Boston area that have conducted extensive preclinical research with hyperpolarized C13
metabolic imaging in the brain, kidneys, liver, and pancreas, and this system would finally allow
translation of many of these studies into the clinical realm. In addition, there are other investigators
in the area who are conducting clinical studies on neuroinflammation, drug response, prostatic
inflammation, and neurodegenerative diseases that would benefit from having a C13 polarizer to
provide new in vivo data on tumor or tissue metabolism.
The proposed C13 polarizer will be located within the Massachusetts General Hospital, at the
center of the Mass General Brigham Cancer Center. The system will be run in partnership with
the Martinos Center, a renowned molecular imaging center known for cutting-edge MR research,
including a preclinical C13 metabolic imaging program, with additional expertise in MEG, PET,
Nano-particle MRI and Optical Imaging. We look forward to sharing this instrument with
researchers and collaborators across the Greater Boston area and throughout New England.

Public health relevance
PROJECT NARRATIVE The proposed shared instrument is a clinical grade, high-throughput carbon-13 (C13) polarizer (The NVision Polaris™). This device, the first of its kind in the New England region, will allow safe human injections of specialized MRI probes that will allow physicians and scientists to better understand how metabolism is changed in a wide range of diseases, from cancer to Alzheimer’s. We can then conduct clinical research by using these new imaging techniques to more accurately determine how these diseases are behaving and responding to treatments.